CVD RISK FACTORS AND BRAIN MORPHOLOGY

To determine the relationship between cardiovascular risk factors collected over the last 25 years, changes in thinking skills and brain structure assessed by MRI in older twins.